Identifying the role of lipid accumulation and foam cells in benign prostate disease

PROJECT SUMMARY/ABSTRACT
Benign prostatic pathological changes (collectively known as Benign Prostatic Hyperplasia/BPH), characterized
by lower urinary tract symptoms (LUTS), is a prevalent condition that significantly impacts the quality of life in
aging males. Current medical treatments for LUTS/BPH are largely ineffective, necessitating a deeper
understanding of the underlying pathogenesis to develop novel therapeutic strategies. Our prior investigation
identified that lipid accumulates in the prostate in BPH as well as macrophages enter the prostate lumen and
become lipid-laden foam cells. However, we have very limited information on the etiology and consequences of
these processes. Therefore, through the utilization of clinical specimens, a well-established mouse model of
prostatic disease, and the creation and testing of novel mouse models, we will investigate the intricate interplay
between prostatic inflammation, lipid accumulation and urinary dysfunction. Accordingly, aim 1 will elucidate the
role of CXCL17 as an epithelia-derived cytokine in remodeling the prostatic immune environment in mice as well
as will identify candidate cytokines that drive the same process in humans via a comprehensive transcriptomic
and proteomic approach. Aim 2 will generate a mouse model with inducible upregulation in lipid synthesis
pathways in the prostate epithelium to assess pathological and functional consequences. Aim 3 will decipher the
impact of foam cell-derived factors via transurethral instillation. Our research team consists of experts in urology,
immunology, and proteomics research, ensuring a comprehensive and multi-faceted approach to address the
research questions. The anticipated outcomes of this research project include a better understanding of the
pathogenesis of LUTS, the identification of novel biomarkers for disease diagnosis and monitoring, and the
development of innovative therapeutic strategies targeting foam cell formation and lipid accumulation.
In conclusion, this study holds significant promise for advancing our understanding of benign prostate disease
and ultimately improving clinical outcomes for patients suffering from lower urinary tract symptoms. By
elucidating the role of lipid accumulation and foam cells, we aim to pave the way for the development of effective
interventions to alleviate the burden of LUTS in the aging male population.

Public health relevance
PROJECT NARRATIVE The molecular basis of BPH initiation and progression remains unclear, impeding advancements in treatment strategies. Our multidisciplinary approach aims to unravel whether lipid accumulation and foamy macrophages drive BPH pathology and urinary symptoms. The results of our study will identify new molecular and cellular targets paving the way for novel therapeutic approaches for this condition.